Circulating microbiome and premature mortality in hemodialysis patients

End stage renal disease (ESRD) is a condition characterized by a disproportionately high risk of premature
cardiovascular (CV) morbidity and mortality, due in part to low-grade chronic inflammation. Efforts to reduce the
inflammatory load in ESRD have been largely unsuccessful. Microbial translocation into the bloodstream can
occur via different routes in ESRD, including contaminated dialysate, dialysis catheter, and impaired intestinal
mucosa, and can be a potential cause of chronic inflammation. While bacterial endotoxins have been extensively
studied among microbial components identifiable in the blood, recent advances in microbial DNA sequencing
have allowed the identification of highly diverse microbial communities in the systemic circulation (a.k.a.
circulating microbiome), even in the absence of overt infection. In addition, both quantitative and qualitative
changes in circulating microbiome have been shown to be associated with conditions linked to chronic
inflammation, such as CV disease, potentially through their immunostimulatory, atherogenic, and cardiotoxic
properties. These results suggest that the circulating microbiome may contribute to the high rates of chronic
inflammation and premature mortality in ESRD. Nevertheless, no work to date has described the nature of the
circulating microbiome and its longitudinal relationships with clinical outcomes in ESRD. The central hypothesis
of this proposal is that microorganisms including bacteria, archaea and fungi are chronically present in the
systemic circulation of patients with ESRD and contribute to the excess risk of chronic inflammation and
premature mortality. The objective of this project is to characterize the circulating microbiome in ESRD and to
investigate its associations with premature mortality. The long-term goal is to elucidate the biological
mechanisms underlying the relationships between circulating microbiome and premature mortality in ESRD. To
test our hypothesis, we propose to analyze longitudinally collected blood samples from a nationwide prospective
cohort of 978 prevalent hemodialysis (HD) patients, with the following specific aims: 1) Determine the levels,
composition, and temporal changes of the circulating microbiome by applying metagenomic sequencing
techniques; 2) Examine the association of circulating microbiome with all-cause and CV mortality, and also
determine if inflammation acts as a mediator of this association; and 3) Identify clinical factors that are associated
with mortality-related circulating microbiome in HD patients by utilizing both traditional regression analyses and
innovative data-driven techniques to discover potentially modifiable risk factors. The findings of our proposed
study will enhance our understanding of the characteristics and roles of circulating microbiome in HD patients
and pave the way for the future development of novel diagnostic and prognostic biomarkers and target-driven
therapeutic strategies to reduce excess risk of mortality in ESRD.

Public health relevance
PROJECT NARRATIVE Recent advances in microbial DNA sequencing have identified highly diverse microbial communities in the systemic circulation (a.k.a. circulating microbiome) among patients with chronic inflammatory diseases even without overt infection; however, the characteristics and roles of circulating microbiome in patients with end- stage renal disease (ESRD) remains largely unknown. Our proposed studies aim to determine the levels, composition, and temporal changes of the circulating microbiome and their associations with clinical characteristics and outcomes in ESRD patients. This research will have the potential to discover novel pathophysiologic roles of the circulating microbiome in ESRD, leading to the development of new diagnostic and prognostic biomarkers and target-driven therapeutic strategies to reduce excess mortality risk in ESRD patients.